CORTICOTROPIN RELEASING FACTOR AND SUPPRESSION OF HUMAN IMMUNE FUNCTION

The overall objective of this study is to investigate the role of CRF in the pathophysiology of neuroimmunomodulation. More specifically, the protocol will determine the effect of exogenous administration of CRF on immune parameters in the following subjects: (1) normal subjects both before and after their HPA axis is inhibited by dexamethasone, (2) subjects with primary adrenal insufficiency on physiological steroid replacement, and (3) ACTH-deficient patients.